Topical treatment for burn pain by blocking cutaneous pain receptors.

Project Summary (Abstract)
Title: Technical and Business Assistance for Commercialization of Topical Treatment
for Burn Pain
This TABA request supports critical commercialization activities for the Phase I SBIR
project. The project focuses on the development of a first-in-class, non-opioid topical
formulation targeting TRPV1 and related cutaneous pain receptors, offering a novel
therapeutic approach for managing burn pain.
This support will directly enhance our readiness for Phase II funding and facilitate
downstream partnering or licensing opportunities. The proposed assistance is essential
to translating our research into a viable therapeutic product that addresses the
significant unmet need in treating burn-related pain.

Public health relevance
Project Narrative (Public Health Relevance Statement) Burn injuries result in severe pain that is often inadequately managed with current treatments, many of which carry the risk of systemic side effects or opioid dependency. Our Phase I SBIR project focuses on a novel, topical, non-opioid therapy for burn pain that targets peripheral pain receptors. The requested TABA funding will help us refine our market, regulatory, and IP strategy, thereby accelerating the development of a safe and effective treatment option that can improve the lives of burn patients and reduce reliance on opioids.